Regulation of Human Epidermal Tumorigenesis by the mRNA Degradation Pathway

Project Summary/Abstract
Background: Transcriptional mechanisms that regulate epidermal homeostasis and
neoplasia have been well established but recently we have discovered that post-
transcriptional mechanisms play prominent roles in maintaining epidermal self-renewal.
We have shown that the 3'-5' mRNA degradation pathway mediated by the exosome
complex is necessary to maintain epidermal self-renewal. Specifically, the exosome
subunits, EXOSC7, EXOSC9, and EXSCO10 are necessary to prevent premature
differentiation of epidermal stem cells by targeting and degrading transcripts that code
for potent pro-differentiation transcription factors.
Objective/hypothesis: This proposal seeks to understand the molecular mechanisms
governing the progression from normal to neoplastic skin using a RAS driven human
epidermal tumor model. Our preliminary data suggests that a 5 subunit exosome
subcomplex is upregulated during tumor initiation and targets/degrades transcripts
coding for factors that would inhibit tumor growth and survival. Our objective is to
characterize the role of each tumor induced exosome subunit in the progression of
normal to neoplastic skin. Furthermore we seek to determine the specific transcripts that
each exosome subunit binds during tumor initiation to promote tumorigenesis.
Specific Aims: (1) To determine the role of exosome subunits on the progression from
normal to neoplastic skin and (2) to identify and characterize the transcripts associated
with exosome subunits.
Study Design: To study epidermal homeostasis in a more clinically relevant setting, we
generate 3-dimensionally intact human skin, containing human epidermal cells (that
have been permanently knocked down for exosome subunits) in the context of human
dermal stroma and basement membrane, regenerated on immune compromised mice.
By using this model, we can perform loss of function experiments on exosome subunits
in regenerated human skin to characterize their role in epidermal growth, differentiation,
and progression to neoplasia. We will use CLIP-Seq to determine the RNAs associated
with the exosome subunits during the progression from normal to neoplastic epidermis.

Public health relevance
Project Narrative Abnormalities in epidermal growth and differentiation result in a wide range of disorders including psoriasis, squamous cell carcinoma, basal cell carcinoma and chronic wounds that negatively impact a large proportion of the U.S. population. This proposal seeks to understand the underlying molecular mechanisms that govern the progression of normal human skin to neoplasia. The efforts of this proposal will define the role of the mRNA degradation pathway in tumor initiation, which may yield insights in the development of therapies for epidermal disorders.